The association of a person-centered care intervention during childbirth with clinical and patient-reported outcomes in Washington state hospitals

PROJECT SUMMARY/ ABSTRACT
Significance: Compared to peer countries, birthing people in the US are more likely to experience
unnecessary interventions during childbirth, making childbirth more expensive while putting birthing people at
an increased risk of adverse pregnancy complications and mortality. A growing body of work estimates that
between 16-20% of women in the US experienced a form of mistreatment during pregnancy care, and
mistreatment may be associated with unnecessary clinical interventions during childbirth, birth trauma, and
mortality. A person-centered approach may be an antidote to disrespectful care, over-intervention, and poor
health outcomes during the perinatal period. TeamBirth is a person-centered care intervention during childbirth
that puts the birthing person at the center of a team-based decision-making process. TeamBirth is currently
being implemented across 55 hospitals in Washington state. While pilot studies have shown that TeamBirth is
feasible and acceptable to implement among clinicians, no studies have tested the association of TeamBirth on
clinical outcomes or patient perceptions of care. Specific Aims: This study leverages an ongoing intervention
across 55 hospitals in Washington state to estimate the impact of TeamBirth on (1) birthing persons’ perceived
autonomy in decision-making during childbirth and (2) Cesarean delivery among low-risk birthing people before
and after implementation of TeamBirth. Approach: The proposed analysis will utilize data from two data
sources: (1) patient surveys administered during in-patient postpartum care and (2) chart abstracted data from
the Obstetrical Care Outcomes Assessment Program (OB COAP) and the Washington State Hospital
Association Maternal Data Center (WSHA-MDC). Using a pre-post design and multiple linear regression, aim 1
will assess the change in birthing persons’ perceived autonomy in decision-making before and after
implementation of TeamBirth. Aim 2 will use a retrospective birth cohort and log-risk regression to estimate the
risk ratio and 95% confidence interval of Cesarean section given exposure to TeamBirth among low-risk
birthing people. Fellowship Information: The applicant is a PhD student in Maternal and Child Health and has
completed a minor in Epidemiology at The University of North Carolina in Chapel Hill. Ms. Spigel’s application
is supported by a multidisciplinary team of mentors with expertise in perinatal nursing, person-centered care,
perinatal epidemiology, applied microeconomics, evaluation of maternal health interventions, and
implementation of TeamBirth. Through coursework in maternal health, epidemiology, quasi-experimental
methods, coupled with support from an exemplary team of mentors, the proposed training plan will assist Ms.
Spigel in successfully completing her dissertation work, and achieving her long-term goal of becoming a
successful independent researcher with expertise in the quality and experience of care during the perinatal
period.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as it leverages an ongoing intervention during childbirth (“TeamBirth”) across 55 hospitals in Washington state to estimate its impact on patient-reported experience measures and clinical interventions during childbirth. Achieving these research aims will provide evidence to support the integration of TeamBirth in labor and delivery rooms across Washington State and throughout the United States, as TeamBirth is being implemented in multiple states and has the potential to be scaled widely. This project supports NICHD’s research priority to set the foundation for healthy pregnancies and lifelong wellness.